BCCMA: Predicting TBI Pathology with Visual and Blood-based Biomarkers

5B09-71+1!C(207D!,E42&4F54G6G5H!4)I17&F8!622D-H5+!7J,K,9L=+M!!1'),N&8(D#-F.$7O6M&%&E,&.,J'.!P#076!+K6,GG(',5!G))M-*6L7!12M)D'4)0H#'-6#Q7>+M'2?#'J!R@<'M2#58C!!,S+745K)T,)-+!C''2M3!)&-4U6+J69D-0&M!7.S607+Q)-,-J&R154U8(5)!F-!1V82,0!M7/-H,!$E!49R,+6+:K(S1'02)L7&,6M8+'-7#UJ)!1K-(Q,02H'#,J4K&,L!6&,M2!1,J!;+M''H7)8!-W9!+51'I+#6&7X-$U4%72R&5H&',D#-2K+S!)5)'Q-(6&17)9U*,2H!W'#'6N#!G+M8'U,95+5H'W6!&F&S7&4Q23<
EUFICFKCDSJHMSJKTEKUYSFCCJWMUFEHJUMWEJUKDFW]MNFFSWGMDCQYUCDJKRSSVUUDFHRF[RJHMWaKUDRMHJMFMYSHEYbFERRCMHRJWKHEUSDFKMKWJEMWUHFLGMVSKFGUHGKDMZSPMMHcKhGG_JXGRLUIMRKKMLUHFFUCFCSKVHWJEKEVDFFHMEWDQJMWKKSUSMHUHQUGW[JFCHaFUSHRSMYMQYUJIgHUKFDSJJHPMCKJYSHRFKKMVUiUUJMRKU[JEMXJ_JCKHcFGYGDSX_JJRU[dDP\dMVDKMGFRJGMWKHTGUMSCGHHKHMWGSeGLHJMUKfGVDKXJXWgMHWUFNh[YDHFFMaQSOGMSRUUEMMKJKJJSMUHPUMJSKRDGYEGCMHSWPFSFKNGJUGGMJCHDKELMUWMEMSDNMMHGKKMYLDQLMUMMMSVVJKJDRHhKFEMMSWHYKYDG
IEVHHaHCFGSSSRFSRJYHMFEKIFGJYXKEKFSDFUGJKkJYUKSSMbUKKMDHEHHNFUHGKSGDVSGMkYEUMgUJFFCUJUePCRILJYDFKHfOGCMKGDlMMgEJE]UUUlJJI[CUFFPDDSHIMVKKGMcSGcFJMIMPVHJMJSMcMMYDMDMHHHSJSDSMSMHUJDUJRGHKXSPMPSZHKUMKJ_JGRRYNPJGaDaHIKFJnSnRXJMgJgHa[JPKRSnHKMGMgGS[hHgYFaNGUPRDbFMMHHUIKUbiSMKFMKHEJSUXKFSLFKMHKSGDUGSMYJLYRKKScGMGbHM_IJHMUcGKF[YS_FaMHYURPWLMkKbFGKGGGbSMHEQHFKScKFUSM_DKMUJYMLUKJUSFKLG[HGKMGaMGJMlMhR]HMHcHWSS__YYKJSGPHEMUKXSXGGJJJSFRHHEmMGcRUKSDFM_FMhSNPNMKMDZKhGMDMGNVUFHDUJMDURKWUUFMUMS]KUEFHFUFSSVQDHKMSHSGXJKCJKJZSKJRLFMHMMj]G
EYpoNFMDHHFFJSEMODMRYDqEWKNJSDUHKDHSF[SJMOMaEMKRREJURFJMEMPPFpEKGKcHGSCS_NYDHMCqJPDEKVFDJFKHKGSFGDSWSEFEFVKFUHSHVESYGKGFSCYKSOECcHYJDJ_MHXINKHQPQMSMKSGYYSGYHMHMJJDDHGSHHUJSJFHMUUSYCJWHYUKJSKMUKNUUMJHJKKHRFEJJEHMSMRGDFISHNVKSFDDMFHMWSOGEMXMMFUEDEQKJQURSHXHFKSJSHKSYFKVEVSJCMHRNEGHMJGSFWUYHHGFHFGYXYJSHUJMQR[KGUjKMgSJSMCQYDHUHWYKYJSHHYQSJKJMHJFKJFCRQHSDMFMS]GSMJFFRMSQNMDJKMKHEDpSHMJMHGYYUFSHMCVJqJDJHEFDFHFEWVSFWYEWrMHKUWUDJEFH[FFOMVSDcEFUJ_[WsaPRHJKFMGGGG

Public health relevance
Blast-mediated traumatic brain injury {TBI} is a leading cause of injury for Veterans. Our central hypothesis is that changes in retinal function and changes in protein expression in the blood are predictive of chronic neuronal dysfunction in the brain. We will developing provocative tests of the retina and additionally evaluate peri-acute and chronic protein biomarkers in order to identify individuals with sub-chronic blast phenotypes. We will also investigate a molecular pathway we have determined to be involved in visual loss following blast exposure. This proposal will generate the data necessary to identify individuals at risk for chronic neurodegeneration as a consequence of blast exposure, and also for the development of therapies that will prevent vision loss in Veterans and improve their quality of life.